Defining the stromal landscape that sustains AML drug resistance

PROJECT SUMMARY:
Acute Myeloid Leukemia (AML) remains a highly fatal disease due to the development of drug resistance during
chemotherapy. The tumor microenvironment, in particular the crosstalk between leukemia cells and bone marrow
mesenchymal stromal cells, has been implicated to be critical for both cancer development and drug resistance.
We recently identified a large number of differentially regulated genes in bulk RNA-sequencing of healthy and
AML stroma that potentially support the survival of leukemic cells within the bone marrow microenvironment.
However, it is unknown if these transcripts are universally up-regulated in stromal cells or if certain pre-existing
subpopulations expand and predominate in the marrow microenvironment to support the survival of leukemia
cells. A corollary of this is that evaluation of bulk stromal cells by itself is insufficient to fully explain the process
and mechanism by which stromal cells mediate AML drug resistance.
As such, the overarching goal of this project is to define the pathological stromal landscape that drives AML drug
resistance. I will test the underlying hypothesis that specific mesenchymal stromal cell subpopulations within
the microenvironment contribute to drug resistance and enable survival of AML cells throughout the course of
therapy. This hypothesis will be tested by performing single-cell RNA-sequencing on AML stroma from patients
(1) before treatment, (2) on-treatment, and (3) following the development of drug resistance. Imaging and
mechanistic studies will also be performed to spatially localize prioritized subpopulations and investigate the
molecular mechanisms that confer drug resistance over time. These data will enable me to identify specific
stromal subsets that are dynamically regulated during the development of resistance and change spatially with
respect to the location of leukemic cells within the microenvironment. Moreover, these data will provide insight
into how these subpopulations alter the AML microenvironment, leading to protection of leukemia cells and,
thereby AML relapse.
The specific aims of this proposal are as follows: (1) Define specific subsets of mesenchymal stromal cells that
correlate with the development of AML drug resistance, and (2) Determine the mechanism by which proteins
expressed by stromal cells confer drug resistance within the AML microenvironment. Results from this proposal
have the potential to create a paradigm shift in the treatment of AML, emphasizing the need to consider extrinsic
mechanisms of resistance that are equally critical in understanding clinical resistance and determining disease
outcomes.

Public health relevance
PROJECT NARRATIVE: In the United States, approximately 20,000 people are diagnosed with Acute Myeloid Leukemia (AML) annually and 11,000 people die from this disease each year. Growing evidence suggests that mesenchymal stromal cells found within the bone marrow microenvironment protect AML cells and, thereby drive relapse after therapy. Defining stromal cell subpopulations and the mechanisms of select candidate proteins expressed by these subpopulations will lay the foundation for improved treatment options and better overall patient outcomes.